NCCIH T32 Complementary and Integrative Health Practitioner Supplement (Molinini)

ABSTRACT
In 2022, the University of North Carolina at Chapel Hill was awarded a T32 competitive renewal grant,
responding to PA-20-142, to fund years 16-20 of the UNC Research Training Program in Complementary and
Integrative Healthcare (CIH). Our goal in this T32 Research Fellowship is to cultivate diverse, talented,
productive, well-trained, independent researchers at both the pre- and post-doctoral level as CIH research
leaders in investigating efficacy, effectiveness, mechanisms of action, and implementation of clinical integration
of complementary therapies and integrative health-care approaches. Our program highlights an
interdisciplinary array of research topics, methodologies and faculty mentors, providing rigorous training in
research methods to facilitate exploration of mind-body techniques and natural-product/nutritional therapies
and their applications in health promotion, chronic pain, metabolic syndrome, and other high-impact conditions,
with emphasis on enhancing access to CIH care in at-risk, underserved populations. The original proposed
Fellowship submission planned for five post-doctoral positions and two pre-doctoral positions; however, our
funded grant was reduced to five overall positions, with NIH/NCCIH providing the opportunity to apply for
supplemental funding for an additional fellow who qualifies as a Complementary and Integrative Health
Practitioner, to enhance NIH goals for diverse practitioner trainees. This application, following NOT-AT-24-033,
proposes the addition of Dr. Rebecca Molinini, as a post-doctoral fellow. Dr. Molinini has a 2010 doctoral
degree in Physical Therapy (DP) and a 2023 PhD in Rehabilitation and Movement Sciences. Her dissertation
research focused on the effect of early motor delay and physical therapy (PT) on the parent-child relationship.
She is committed to continuing her research career in PT with an emphasis on the role of mind-body therapies
in enhancing the parent-child relationship as part of the rehabilitation process for pre-term infants. This is a
high-need area of research, with a dearth of practitioners trained in both pediatric PT and integrative health
research. Dr. Molinini’s proposed training plan includes required training in the Responsible Conduct of
Research, Rigor and Reproducibility, Integrative Health, and mindfulness. She will also take short courses and
training to build her skills in qualitative research methods, rehabilitation research grantsmanship, and
neuroimaging research methods. In addition, Dr. Molinini proposes to enhance her training related to
mindfulness and self-compassion and their relevance to the parent-child relationship in rehabilitation. Dr.
Molinini will be mentored by a team of experienced UNC faculty with combined expertise in PT research (Dr.
Lewek and Dr. Cassidy), mindfulness research and integrative health research methodology (Dr. Gaylord and
Dr. Lathren), and neuroimaging/EEG (Dr. Cassidy). The department of Physical Medicine and Rehabilitation,
where the T32 resides, is an ideal setting for this trainee’s career maturation and learning to take place.

Public health relevance
PROJECT NARRATIVE This application utilizes the Complementary and Integrative Health (CIH) Practitioner Supplement to expand our long established, successful NIH T32 training grant that has provided rigorous training to pre- and post- doctoral fellows who have become skilled leaders in CIH research. In this supplementary application, we propose a two-year training program for Dr. Rebecca Molinini, a promising future leader with a doctoral degree in Physical Therapy and a PhD in Rehabilitation and Movement Sciences who is committed to research in mind-body therapies for enhancing the parent-child relationship as part of the rehabilitation process for preterm infants. Dr. Molinini will learn mind-body therapy research methods, neuroimaging/EEG, and be trained in safety, efficacy, effectiveness, and implementation strategies for integrating effective CIH therapies into health care practice.